Atopic dermatitis in childhood and risk of early cardiovascular disease

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease, the leading cause of death worldwide, often begins in childhood. Cardiovascular risk
factors including hypertension, dyslipidemia, insulin resistance, and obesity can be detected before
adolescence and are highly predictive of later life cardiovascular morbidity and mortality. Similarly, in
adolescence and early adulthood, subclinical evidence of atherosclerotic disease based on non-invasive
imaging and measures of endothelial function are important predictors of long-term risk. Children with specific
underlying conditions, including chronic inflammatory disease, have been identified by the American Heart
Association as having an increased risk for accelerated atherosclerosis and early cardiovascular disease, and
specific screening and therapeutic targets have been proposed for these children.
There has been a recent paradigm shift towards understanding atopic dermatitis as a systemic inflammatory
condition and severe atopic dermatitis in adults has been associated with cardiovascular outcomes, but very
little is known about the possible association between atopic dermatitis and cardiovascular risk among
children. It is important to address this research gap because atopic dermatitis is the most common chronic
inflammatory disease of children, affecting up to 25% of the population.
The overall objective of this proposal to evaluate whether atopic dermatitis is associated with cardiovascular
risk factors and subclinical atherosclerosis in children and young adults. We propose a secondary analysis of
the Avon Longitudinal Study of Parents and Children (ALSPAC), a population-based birth cohort of 14,000
individuals designed to study health and development with over 20 years of follow-up. This cohort is unique in
that it contains repeated assessments of atopic dermatitis severity and detailed measures of cardiovascular
risk.
Specifically, we will (1) examine the extent to which atopic dermatitis is associated with contemporaneous
hypertension, insulin resistance, dyslipidemia, and obesity at twelve time points between birth and age 17, and
(2) determine if subgroups of individuals with a more active and severe pattern of atopic dermatitis throughout
childhood and adolescence have evidence of subclinical atherosclerosis as measured by carotid intima-media
thickness, distensibility coefficients, and pulse wave velocity at ages 17 and 24.
The proposed research will lead to a better understanding of how atopic dermatitis disease activity and severity
over time affect cardiovascular risk in early life. This research which will provide a proof of principle to justify a
prospective cohort study designed to better characterize temporal changes in cardiovascular risk and identify
potential mechanisms among subgroups of patients with atopic dermatitis, and provide preliminary data to plan
future comparative clinical trials of the impact of atopic dermatitis treatment on early cardiovascular risk, timely
now with many new targeted anti-inflammatory biologic treatments approved and/or in testing.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of death worldwide, and often begins in childhood. Children with chronic inflammatory disease have been identified by the American Heart Association as having an increased risk for accelerated atherosclerosis and early cardiovascular disease, but little research has addressed whether atopic dermatitis, which affects up to 25% of children, is associated with increased risk. This gap is important to address because early intervention may mitigate long-term mortality.